TOPICAL 1,25 VITAMIN D3 IN CHILDREN WITH PSORIASIS

It has been shown that the active form of vitamin D3,1,25-dyhydroxyviatmin D3, has biological effects on human skin.Psoriasis is caused by abnormally rapid growth of skin cells. We have demonstrated that this vitamin D compound decreases the growth rate of normal cells in adults. We are interested in determining whether 1,25 (OH)2D3 is useful for treating psoriasis in children ages 4 through 18 years.